THE UCLA FAMILIAL CANCER REGISTRY AND GENETIC EVALUATION PROGRAM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To establish a familial cancer registry of high risk individuals and families whose informed consent participation may contribute to other genetic and non-genetic research protocols.